Research Training in Rehabilitation for Brain Injury and Neurological Disability

Project Summary
This is an application for the competitive renewal of a T32 Institutional National Research Service
Award for a successful postdoctoral training program in medical rehabilitation research that
focuses on brain injury and neurological disability. We propose to train 4 postdoctoral level trainees
per year, each for a total duration of 2-3 years. The training program is based in the Kennedy
Krieger Institute and Johns Hopkins Department of Physical Medicine and Rehabilitation (PM&R)
and in Baltimore. Kennedy Krieger is a major center for clinical care and research on neurological
disabilities in children and young adults on the Johns Hopkins University medical campus.
Trainees can work with any of the 29 faculty advisors from the Kennedy Krieger Institute, the
Department of PM&R, Neurology, Neuroscience, Pediatrics, Radiology, Biomedical Engineering
and Biostatistics at Johns Hopkins. The mission of our program is to educate a diverse group of
postdoctoral researchers in the science of neurorehabilitation with the goal of improving outcomes
for children and adults with neurologically based disabilities We do so via an equitable training
environment that focuses on collaboration in research and clinical practice. Our vision is to
harness scientific discoveries from fields such as neuroscience, biomedical engineering,
neurology, and psychology and apply them to populations with damage to the nervous system. In
this way, our program fulfills a national need to transfer science and technology more quickly to
the bedside. The goals of the program are to 1) train clinicians and basic scientists who will go on
to make important contributions that advance the rehabilitation of patients with brain and spinal
cord injuries and other neurological disabilities; 2) equip these trainees with the skills needed to
become independent grant-funded investigators. The focus of the training program is on a
mentored period of hypothesis-driven translational clinical and/or laboratory based research.
Faculty have expertise in one or more of three major rehabilitation themes: 1) recovery mechanisms
in neurorehabilitation; 2) pediatric brain injury rehabilitation; 3) stroke rehabilitation. A training
program executive committee provides specific goals for progress of trainees to achieve core
research competencies, and they monitor progress closely. The program provides a strong
curriculum of weekly conferences, journal clubs and didactic lectures that reflect the research and
scholarly environment at Johns Hopkins. The program has trained more than 50 researchers since
its inception, many of which now have highly productive rehabilitation research programs.

Public health relevance
Project Narrative This training program is directly related to improving treatment and reducing disability for millions of children and adults with disorders of the nervous system. Our focus is on training MD and PhD researchers to develop and assess new rehabilitation approaches for people suffering from many different disorders of the nervous system, including traumatic brain injury, stroke, and developmental brain disorders.